COLONIC MOTOR SENSORY FUNCTION DURING HYPERVENTILATION

The principal aim of the study is to assess colonic motor and sensory responses in response to eucapnic and hypocapnic hyperventilation, the concomitant hemodynamic changes and the underlying physiologic mechanisms.